Structural regulation of megalin recycling in the proximal tubule

Abstract
This K08 Career Development Proposal details the candidate’s research on the structural regulation of megalin
recycling in the kidney proximal tubule (PT) that will be conducted during a 5-year mentored award period.
With the guidance of his co-mentors at Columbia University, Dr. Shapiro and Dr. Barasch, along with oversight
from an experienced multi-institutional advisory committee, Dr. Beenken has designed a comprehensive plan
of didactics and intensive laboratory research in cryo-electron microscopy (cryo-EM) and mass spectrometry.
This training will enable him to differentiate himself from his mentors and develop a body of research that he
can use to start an independent research laboratory as a physician-scientist. His ultimate goal is to translate
the understanding of structural mechanisms of megalin recycling to new treatments for proteinuric disease.
Megalin-dependent endocytosis in the PT enables protein capture that protects the kidney tubules from
damage due to proteinuria. Megalin must recycle between cell surface and endosomes to fulfill its endocytic
function, but the structural mechanisms that underlie this recycling are poorly understood. Dr. Beenken has
published cryo-EM structures of megalin at pH 7.5 and 5.2, revealing megalin’s structure at the cell surface
and in the late endosome. These structures demonstrated that megalin undergoes extensive pH-dependent
structural transitions to bind ligands from the urinary filtrate at the cell surface and then shed ligands in the
acidic endosomes. Dr. Beenken’s work led him to hypothesize that megalin adopts unique structures in
different endosomal compartments that are regulated by specific residues in megalin and depend on changes
in megalin’s coordination of Ca2+ ions. In his proposed research project, Dr. Beenken will test his hypothesis by
determining structures of megalin in different endosomal compartments including early and recycling
endosomes (Aim 1), characterizing pH-sensitive megalin residues during trafficking (Aim 2), and determining
the dependence of megalin recycling on Ca2+-coordination (Aim 3). Pursuing these research goals will lay the
groundwork for Dr. Beenken’s career in the structural biology of megalin receptor recycling in the PT and
enable him to become an independent investigator. Ultimately, he plans for his discoveries in the basic science
of megalin recycling in the PT to translate to clinical interventions for proteinuric disease.

Public health relevance
Narrative Megalin captures proteins from the urinary space to produce an essentially protein-free urine, thereby protecting the kidney tubules from damage caused by proteinuria. Megalin recycles between cell surface and intracellular compartments to carry out this function, but the molecular basis for this recycling is not well understood. I will use structural approaches to study the molecular basis of its recycling.